Regulation of Ephrin Receptor Expression in the Retina

PROJECT SUMMARY In the developing retina, gradients of ephrin receptor (Eph) expression along the dorsal/ventral (EphB) and nasal/temporal (EphA) axes of the retina create positional information necessary for the topographic organization of retinal ganglion cell (RGC) axon terminals in the brain. Despite their importance in visual system development, the cellular mechanisms regulating the cellular and spatial patterns of Eph receptor expression in the retina are not well understood. The long term goal of this research program is to determine the transcriptional mechanisms that pattern the cellular and spatial patterns of EPH receptor expression in the developing retina. The central hypothesis of this proposal is that combinatorial effects of transcription factors and chromatin modifications regulate the nasal low/temporal high expression of EphA5 in retinal ganglion cells. We have cloned the EphA5 promoter and have data showing Pou4F2/Brn3b can activate the promoter in vitro. In the retina, Pou4 transcription factors are expressed specifically in RGCs and are required for their differentiation and the establishment of a normal retinotopic map. In Specific Aim 1, we will determine the role of transcription factors in regulating EphA5 promoter activity in RGCs. To test our working hypothesis that Pou4/Brn3 transcription factors regulate EphA5 expression RGCs, we will determine which Pou4 factors occupy predicted binding sites in the EphA5 promoter, if there are differences in promoter binding in the nasal and temporal retina and if loss of Pou4F2 disrupts EphA5 expression in the developing retina. We will then determine if Pou4F binding sites are necessary for EphA5 promoter activity in vitro and in vivo. Because Pou4 transcription factors are not expressed in gradients, additional mechanisms are required for down-regulating EphA5 expression in the nasal retina. We have identified spatial differences in methylation in EphA5 promoter methylation that correlate with spatial differences in mRNA expression and shown that methylation modulates EphA5 promoter activity. KLF transcription factors are expressed in RGCs in vivo and can differentially promote or block RGC axon outgrowth. In Specific Aim 2, we will determine the role of differential DNA methylation in regulating spatial differences in EphA5 expression in the retina. Our working hypothesis is that differential methylation regulates spatial patterns of EphA5 expression by altering recruitment of KLF transcription factors. To test this, we will determine the full extent of DNA methylation across the EphA5 promoter and identify which retinal cell types have differential methylation. We will determine which KLF transcription factors regulate the EphA5 promoter in vitro and how DNA methylation alters binding specificity and promoter activation. The proposed research will result in increased understanding of the mechanisms that regulate EphA5 expression in the retina. This information will be important for the future development of novel therapies to replace RGCs and regenerate the optic nerve, because successful restoration of functional vision will require new RGCs to re-establish topographically ordered connections in the visual centers in the brain.

Public health relevance
PROJECT NARRATIVE Successful development of regenerative therapies to restore vision in patients with blinding diseases including glaucoma and optic neuropathy will require that regenerated retinal ganglion cells re-establish their connections to appropriate targets within the visual centers of the brain. This research seeks to understand the cellular mechanisms that control the normal expression patterns of specific genes that guide retinal ganglion cell axons and pattern their connections during development. This fundamental knowledge will be a critical component for identifying strategies to enhance optic nerve regeneration and, ultimately, to restore vision. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In the developing retina, gradients of Eph receptor expression along the dorsal/ventral (EphB) and nasal/temporal (EphA) axes of the retina create positional information that patterns the termination of retinal ganglion cell (RGC) axons in the brain (Scicolone et al. 2009). In the mouse, EphA5 is expressed in temporal high/nasal low gradient (Brown et al. 2000; Feldheim et al. 2004) and mice lacking EphA5, show targeting errors in the superior colliculus (Feldheim et al. 2004). Despite the importance of EPH signaling in the formation of topographic maps, the molecular mechanisms that regulate the cellular and spatial patterns of EPH receptor expression in the retina are not well understood. The long term goal of this research program is to determine the transcriptional mechanisms that regulate the cellular and spatial patterns of EPH receptor expression in the developing retina. The overall objective of this application is to determine the mechanisms regulating EphA5 expression in RGCs. First, we cloned the mouse EphA5 proximal promoter and identified potential binding sites for POU4 family transcription factors. Using luciferase assays, we found that Pou4f2/Brn3b activated the EphA5 promoter. Pou4f2 is required to establish a normal retinotectal map (Erkman et al. 2000; Wang et al. 2000); however, Pou4f2 is not expressed in a gradient. Therefore, additional mechanisms are required for down-regulating EphA5 expression in the nasal retina. Second, we have published data showing that in the nasal retina, there is elevated DNA methylation in the EphA5 promoter (Petkova et al. 2010). Furthermore, this region of the EphA5 promoter contains multiple predicted binding sites for SP/KLF transcription factors, which function as transcriptional activators or repressors depending on the promoter context (Otteson et al. 2004; Pearson et al. 2008; Wade et al. 2010). Multiple KLF transcription factors are expressed in RGCs and, when over-expressed in RGCs, differentially promote or block axon outgrowth in vitro (Moore et al. 2009). The central hypothesis of this proposal is that combinatorial effects of transcription factors and chromatin modifications regulate the nasal low/temporal high expression of EphA5 in retinal ganglion cells (Fig. 1). 1. Determine the transcriptional mechanisms regulating EphA5 promoter activity in RGCs. Our working hypothesis is that Pou4f2/Brn3b directly regulates expression of EphA5 in RGCs in vivo. 2. Determine how differential methylation regulates graded EphA5 expression. Our working hypothesis is that localized methylation in the EphA5 promoter regulates differential binding and transactivation or repression by KLF transcription factors. Figure 1. Proposed models for regulation of EphA5 expression in retinal ganglion cells. (A) In the temporal retina, EphA5 expression is increased by the combined effects of POU4F2 and KLF transcription factors binding to consensus sites in the unmethylated promoter. (B) Methylation of binding sites in the nasal retina prevents binding by KLF activators, leading to reduction in expression relative to temporal retina. (C) Alternatively, methylation of consensus sites in nasal retina alters the affinity of KLF binding, resulting in recruitment of KLF repressors that overcome promoter activation by POU4F2. The expected outcomes of the proposed research will be an increased understanding of the mechanisms that regulate EphA5 expression in the retina. Specifically, we expect to show that Pou4f2 drives promoter activity in RGCs and that site-specific methylation alters activation or repression of the EphA5 promoter by specific KLF transcription factors. This will have a positive impact by increasing our fundamental understanding of the transcriptional mechanisms that regulate EphA5 receptor gene expression in the retina. This information will be important for the future development of therapies to replace RGCs and regenerate the optic nerve in patients with glaucoma or other degenerative diseases. This is because successful restoration of functional vision will require that new RGCs re-express Eph receptors in the appropriate, cellular and spatial patterns before they will be able to re-establish topographically ordered connections within the visual centers of the brain.